CSHL Course on Methods in Cancer Neuroscience (2025-2029)

Abstract
The proposed Cold Spring Harbor Laboratory (CSHL) course Methods in Cancer Neuroscience (MCN), to be
held annually starting in March 2025, is part of the advanced postgraduate courses offered by the CSHL
Meetings & Courses Program. MCN is a short, intensive sixteen day hands-on course which prepares students
to enter directly into research that makes use of advanced and/or specialized molecular and cellular techniques
in cancer neuroscience. Experimental modules in the course will include preparation of cell suspensions for
injections, intracranial cell injections, peripheral tumor cell, injections, intra-cardiac and tail vein models of
metastasis, viral injections and fiber optic placement for optogenetics (CNS), cranial window implantation, virus
injections for neuronal tract tracing, behavioral assays and analysis, primary neuron isolation and co-culture with
cancer cells, immune cell & neuron co-culture with cancer cells, and stable cell line generation, in vivo
electrophysiology and data analysis, immunolabeling of co-cultures, electron microscopy (lecture only),
fluorescent reporters for in vivo video-microscopy, two-photon microscopy, neurite outgrowth, clonogenic
assays, and other functional assays, mouse brain organotypic cultures, advanced analysis of calcium reporters,
tissue preparation for 10x scRNA-seq and data analysis, among other techniques. Experimental techniques are
taught in the context of the broader conceptual advances that they may provide. The course invites lecturers
who have made significant contributions in their fields to give up-to-the-minute reports on current research. The
trainees are chosen by the course faculty from larger pools of applicants and range from graduate students to
senior investigators and research physicians. Because of the short duration of this course, senior, as well as
junior individuals can attend and receive a short, intense period of training in an environment remote from other
demands on their time and attention. The MCN course also provides an unusual opportunity for established
scientists to apply these advanced techniques to their own research interests, or to retrain in an important
specialty within cancer neuroscience with which they may not be familiar. Methods and concepts taught in the
course are disseminated to the wider research community through the publication of laboratory manuals and
online resources.

Public health relevance
Project Narrative This application seeks funds to support an advanced neuroscience lab-based short course at Cold Spring Harbor Laboratory, New York. The course aims to provide advanced training in state-of-the-art approaches in cancer neuroscience. Trainees include advanced graduate students, postdoctoral researchers and young faculty from throughout the United States and abroad. The selection process for entry into these courses is highly competitive, and trainees leave the course armed with new techniques, know-how and potential collaborators to apply to their own areas of research. A significant proportion of trainees subsequently undertake basic or applied research in cancer neuroscience. Methods and concepts taught in the course are disseminated to the wider research community through the publication of laboratory manuals and online resources.